Administrative Supplements for the NCI P30 Cancer Center Support Grants for Multi-Channel Communication Campaigns for Improvements in Cancer Education and Outcomes (MICEO) in Underserved Populations

Abstract
The catchment area of Karmanos Cancer Institute (KCI) includes Southeast Michigan and the city of
Detroit. According to the 2022 U.S. Census, 78% of Detroiters identify as Black, 32% live in poverty compared
to 13% in the state of Michigan, and the majority of census tracts in the city of Detroit are medically
underserved areas (MUAs) based on HRSA definitions. Engaging this population in cancer prevention and
control efforts is essential. In the proposed work, we will address Track 2 with a focus on the General
Population (30+ years) and breast cancer screening. Our preliminary work suggests some delay in
mammography screening due to the COVID-19 pandemic, consistent with other work indicating missed or
delayed cancer screenings in the first year of the pandemic 1 2 and lower than pre-pandemic screening levels
in the second year 3, raising concerns about a future risk in late-stage diagnoses. This is especially concerning
given the breast cancer mortality rates of 34.3 per 100,000 among Black women in Detroit compared to 21.3
per 100,00 among White women in the KCI catchment area. Breast cancer screening promotion is consistent
with an emerging KCI OCHECE initiative: Karmanos Academy, a program with the primary goal of building
community capacity for improving cancer prevention and control throughout the KCI catchment area. Through
Karmanos Academy, community members will be trained as lay health advisors (LHAs) to deliver relevant
interventions within local organizations and institutions as well as their own social networks. The proposed
work has three aims: Aim 1: Adapt an existing LHA-led psychoeducational program to increase
mammography adherence among Black women in the metropolitan Detroit area in collaboration with
community stakeholders; Aim 2: Collaborate with existing KCI OCHECE community partners to enlist and
train community members as LHAs who will deliver the adapted psychoeducational program; Aim 3: Partner
with KCI's Marketing and Business Development Department to develop and implement a social media toolkit
to promote mammography adherence among Black women in the metropolitan Detroit area. We will create a
video-based adaptation of the Real Talk intervention to increase mammography adherence among Black
women aged 40 years and older. This video will be an integral part of LHA-led sessions on this topic, session
coordinated in tandem with a social media campaign. Ultimately, the proposed work will improve cancer
literacy and breast cancer knowledge among Black women in metro Detroit through strategic use of multiple
communication channels.

Public health relevance
Not Applicable